Predicting Ipsilesional Motor Deficits in Stroke with Dynamic Dominance Model

DESCRIPTION (provided by applicant): Unilateral sensory-motor stroke can cause significant motor deficits in the arm and leg on the same side of the body as the lesion (ipsilesional), in addition to producing more severe deficits on the opposite side of the body (contralesional). While ipsilesional deficits have been recognized in the clinic for decades, therapeutic attention has understandably focused on the more severe nature of contralesional deficits. However, ipsilesional deficits have recently been shown to substantially limit efficient performance of functional tasks, including activities of daily living. Such limitations are not difficult to understand given that the ipsilesional arm tends to be used as the primary manipulator during both unimanual and bimanual tasks for patients with moderate to severe hemiparesis. These coordination deficits are thought to result from diminished contributions from the damaged hemisphere to control of the arm on the same side of the body, an idea supported by our preliminary studies. Based on the dynamic dominance model of motor lateralization, we hope to explain and predict the differential deficits in unimanual and bimanual coordination that result from either right or left hemisphere damage. The proposed studies exploit the expertise of two laboratories that have invested substantial effort in studying motor lateralization (Sainburg), and ipsilesional motor performance in stroke patients (Haaland). [We expect our results to have tangible applications to rehabilitation, including the development of interventions to improve ipsilesional and bilateral function in chronic stroke patients.] Our proposed experiments examine targeted reaching movements, using a custom designed virtual-reality system that allows real-time display and recording of bilateral arm movements. The first two aims directly examine predictions from our model of lateralization for ipsilesional motor control and learning. Specifically, we will examine whether intersegmental coordination deficits result from left hemisphere damage, while positional deficits result from right hemisphere damage. In addition, we will examine the potential effect of such coordination deficits on functional performance. Our second aim examines whether unilateral stroke produces motor learning deficits that vary with the side of the lesion. Our third and fourth aims address the specific control processes that might underlie ipsilesional deficits: First, we ask whether left hemisphere related deficits in coordination and adaptation are related to errors in predicting task dynamics. Second, we examine whether position errors that result from right hemisphere damage are accounted for by deficient impedance control mechanisms, or rather by deficits in specification of spatial locations. In our final study, we will test our model's predictions for bilateral coordination during virtual object transportation and manipulation tasks. This is particular important for patients with moderate to severe hemiparesis, who often rely on bimanual arm use to carry out activities of daily living. In addition, recent research has indicated that bilateral exercise can serve as an effective therapeutic modality for such patients (Harris-Love et al, 2005). !

Public health relevance
PUBLIC HEALTH RELEVANCE: The American Heart Association reports that each year, about 780,000 people in the United States experience a new or recurrent stroke, a large proportion of which involves asymmetrical damage to the cerebral hemispheres. Because the cerebral hemispheres are not functional mirror images of one another, lesion to either hemisphere can produce unique deficits in both arms of stroke patients, including the non-paretic arm. The studies proposed here should lead to a more complete understanding of motor deficits in the non-paretic arm of stroke patients, and the effects of these deficits on both unimanual and bimanual coordination. This is particularly important for patients with moderate to severe hemiparesis, who tend to rely on the non-paretic arm to carry out activities of daily living. We expect that our findings should produce tangible applications to clinical rehabilitation, and to rehabilitation research. The American Heart Association reports that each year, about 780,000 people in the United States experience a new or recurrent stroke, a large proportion of which involves asymmetrical damage to the cerebral hemispheres. Because the cerebral hemispheres are not functional mirror images of one another, lesion to either hemisphere can produce unique deficits in both arms of stroke patients, including the non-paretic arm. The studies proposed here should lead to a more complete understanding of motor deficits in the non-paretic arm of stroke patients, and the effects of these deficits on both unimanual and bimanual coordination. This is particularly important for patients with moderate to severe hemiparesis, who tend to rely on the non-paretic arm to carry out activities of daily living. We expect that our findings should produce tangible applications to clinical rehabilitation, and to rehabilitation research. __SpecificAimsTextDelimiter__ A. Specific Aims Unilateral sensory-motor strokes that result in hemiparesis of the contralesional limbs often produce motor deficits in the ipsilesional arm that substantially limit efficient performance of functional tasks, including activities of daily living. We hypothesize that our model of motor lateralization might explain and predict the ipsilesional motor deficits that result from right or left hemisphere damage. This, in turn, should help in the development of remedial strategies to ameliorate such deficits. All of the proposed studies will be conducted in right-handed stroke patients, such that the left hemisphere is contralateral to the dominant hand, and the right hemisphere to the non-dominant hand. Ipsilesional performance of hemiparetic stroke patients will always be compared to that of age-matched control subjects using the same arm. Sensory-motor stroke refers to unilateral strokes that result in contralesional hemiparesis (see inclusion criteria). 1. To determine whether left, but not right, sensory-motor stroke produces ipsilesional deficits in intersegmental coordination during unsupported 3-D reaching tasks. Our preliminary study describes our published results from the first aim of our initial proposal. This study demonstrates that left, but not right hemisphere damage produces deficits in intersegmental coordination during horizontal plane reaching movements, when gravity and friction loads were eliminated. However, such movements are quite removed from the natural reaching movements required of patients during daily activities. We are now able to extend this aim to examine performance during unsupported vertical reaching movements in a natural gravity environment, and to examine whether measured deficits in coordination are related to functional test results. 2. To determine whether sensory-motor stroke results in ipsilesional motor learning deficits that depend on the side of the lesion. While many studies have demonstrated that ipsilesional coordination deficits in stroke patients can be functionally limiting, the effects on motor adaptation are not well understood. Our model of motor lateralization suggests that each hemisphere/limb system employs cost functions relevant to its specialized mechanisms, and thus predicts qualitatively different adaptation deficits associated with left and right hemisphere damage. We will examine this hypothesis by examining adaptation to novel visuomotor rotations. Dominant hemisphere/arm specialization for predictive control of movement trajectory suggests that LHD will interfere with adaptations in trajectory direction over the course of learning. In contrast, non-dominant specialization for control of steady state position predicts that RHD will interfere with corrections to the final position made within each trial, but not with inter-trial directional adaptations. 3. To determine whether left and right sensory-motor strokes differentially disrupt predictive and impedance control mechanisms during adaptation to novel inertial dynamics. Previous research has shown that dynamic adaptation relies on two qualitatively different processes: 1) predictive control of the effects of the applied load, and 2) impedance mechanisms that reduce the perturbing effects of the applied load. While both mechanisms are normally employed in novel task environments, the dominant and non- dominant arms rely more heavily on each process, respectively. We hypothesize that RHD will produce deficits in impedance control, while LHD will produce deficits in predictive control, as revealed during the course of adaptation to novel inertial dynamics. 4. To determine the mechanisms that might underlie right hemisphere advantages and left hemisphere deficits in positional accuracy. Our preliminary studies revealed robust final position accuracy advantages for the right hemisphere/left arm system in both healthy control subjects and in the ipsilesional performance of LHD patients. We now propose to discriminate whether these findings might result from advantages in spatial specification mechanisms or rather in impedance control asociated with stoping at a specified target location. This will be done by comparing reversal movements, without a postural phase at the target, to movements that are required to stop on the target. 5. Aim 5: To determine whether left and right sensory-motor stroke differentially disrupts bimanual coordination during virtual object manipulations. We will examine how bimanual coordination might be differentially affected by right and left hemisphere damage. This is particularly important because recent research has suggested that bilateral movements can recruit brain tissue that is not normally activated during unilateral activity, and that this recruitment may play a role in functional motor recovery (Cauraugh and Summers 2005; Lewis and Byblow 2004). We will examine the effects of left and right hemisphere damage on bilateral virtual object manipulation tasks that require either symmetric movements for object transport, or that require one hand to stabilize while the other moves for object manipulations.